Molecular and Genetic Predictors of Disability Progression in MS

DESCRIPTION (provided by applicant): Multiple Sclerosis (MS) is the most common cause of acquired neurological dysfunction during early and mid adulthood, and affects more than one million people in North America and Western Europe. Compelling data indicate that susceptibility and resistance to MS is partly inherited. The presence of brain inflammation, loss of myelin and neuro-axonal degeneration are hallmarks of the disease. However, the link between these pathological processes remains unknown. An emerging concept bridging this knowledge gap is the alteration of glutamate metabolism causing toxicity of the central nervous system. Clinically, the vast majority of MS patients will experience progressive worsening a decade after onset of the disease. The main goal of this study is to determine the level of brain glutamate in patients with MS using a novel molecular magnetic resonance imaging technique. This non-invasive in vivo methodology provides, for the first time, an estimate of glutamate levels over large brain regions of interest. Specifically, the authors hypothesized that an excess of glutamate levels in MS patient brains is a predictor of neuronal injury, brain atrophy and accumulation of chronic clinical disability. Lastly, the effort will focus on the discovery of patterns of gene expression in the peripheral blood of MS patients through the combined use of state-of- the-art genome wide analysis and molecular biology experimental tools to predict sustained disability progression of MS patients. The authors will use unsupervised and supervised machine learning algorithms to capture relationships between gene expression levels and disease progression. PUBLIC HEALTH RELEVANCE: The identification of specific molecular imaging and genetic predictive markers associated with disease progression of MS patients will accelerate advances in research and lead to better therapeutic strategies to prevent the biological process leading to brain inflammation, demyelination, axonal injury and consequent progressive neurological deficits.

Public health relevance
PROJECT NARRATIVE The identification of specific molecular imaging and genetic predictive markers associated with disease progression of MS patients will accelerate advances in research and lead to better therapeutic strategies to prevent the biological process leading to brain inflammation, demyelination, axonal injury and consequent progressive neurological deficits.